Liver-Gut Axis in Neonatal Anemia and Its Role in RBC Transfusion Associated Gut Injury

Project summary
Anemia is a nearly universal diagnosis in preterm infants, caused primarily by phlebotomy essential for medical
care, though also exacerbated by a variety of factors inherent to immaturity in the ex utero environment. When
severe enough to be treated with RBC transfusion, clinicians must be aware of the risk of critical adverse effects
such as necrotizing enterocolitis (NEC), an inflammatory bowel necrosis characterized by macrophage
infiltration, and a leading cause of mortality in those born between 22 and 28 weeks gestation. We have recently
elucidated the connection between anemia and NEC, specifically, the “leaky gut” presentation characterized by
macrophage infiltration, RBC transfusion-associated activation of infiltrated macrophages, and the resulting
intestinal mucosal injury. Our long-term objective is to study the anemia-induced immunity changes in the
neonatal liver and their contribution to gut mucosal injury during RBC transfusion. Our preliminary studies using
our existing pre-clinical murine model of anemia demonstrate that anemia is associated with recruitment of a
unique population of monocyte (CD11bhiF4/80midLy6Cmid) expressing triggered myeloid receptor 1 (trem1),
similarly to monocytes developing in the neonatal liver but unlike those in the bone marrow or spleen. Consistent
with this, neonatal anemic liver monocytes displayed greater inflammatory activation to heme (found in stored
RBC) than did bone-marrow derived cells. This inflammatory response could be dampened either by the use of
anti-trem1 antibody treatment or by silencing monocyte trem1 expression. Taken together, the investigators
propose a novel hypothesis that in the setting of anemia, a gut-liver-gut boomerang effect is noted as the leaky
gut and associated bacterial translocation during anemia communicate via the portal vein to the liver, trigger the
expansion of hepatic leukocyte populations developing in situ which proceed to infiltrate the anemic intestine,
predisposing to RBC-associated gut injury. To test our central hypothesis, we will pursue the following specific
aims: Aim 1: Elucidate the ontogeny of macrophages recruited to the neonatal intestine during anemia. Aim 2:
Define the role of trem1 signaling on the migration of hepatic monocytes into the anemic intestine, and on the
inflammatory activation during RBC transfusion. Aim 3: Determine whether therapeutic targeting of hepatic
trem1+ monocytes during anemia can prevent/ attenuate RBC-transfusion associated NEC-like injury.
Accomplishment of the proposed aims will develop an effective therapeutic strategy of inhibiting the hepatic
response during anemia without suppressing protective innate immune mechanisms.

Public health relevance
Project Narrative Anemia is a nearly universal diagnosis in preterm infants and is associated with increased morbidity and mortality worldwide. When severe enough to be treated with RBC transfusion, critical adverse effects can be seen; one such consequence is necrotizing enterocolitis (NEC), an inflammatory bowel necrosis of preterm infants characterized by macrophage infiltration and activation. In this application, the investigators propose sequential studies to investigate the ontogeny of implicated macrophages, the mechanism(s) involved in their recruitment, and potential strategies to prevent their activation in the progression to NEC.